Research Capacity Core

PROJECT SUMMARY
The Southwest Heath Equity Research Collaborative (SHERC) Research Capacity Core (RCC) is responsible
for supporting SHERC efforts expanding the research capacity of Northern Arizona University (NAU) faculty,
staff, and core research facilities to conduct cutting-edge health equity research. RCC will provide capacity-
building resources for contemporary qualitative and quantitative data analysis methodologies, facilitate cross-
disciplinary research activities, and provide capacity-building resources to NAU researchers and community
partners, with a special focus on early-stage investigators. RCC’s primary function is to ensure the success of
all SHERC research projects and faculty by providing access to computing, statistical, and research design
expertise. RCC will also work across campus and with our RCMI/CTSI partners to maximize the potential for
multidisciplinary collaborations that address ongoing and emerging health disparities in the southwestern
United States (US). The specific aims of the RCC are to: (1) renovate the NAU’s computational core facility; (2)
sustain and expand the new Technical Assistance Group Service Center (TAG-SC), which provides support for
qualitative and quantitative research methodology, community-engaged research design, specialized
laboratory techniques, statistics, bioinformatics and/or health informatics, and other data science
methodologies; (3) continue to enhance the successful RCC Methodological Dissemination Program by
providing leading-edge expertise, training, and collaborative opportunities for innovative research development
with an emphasis on enhancing multidisciplinary team science approaches and community-engaged research;
and (4) expand the RCC Capacity Enhancement Program to support equipment, data, and computing resource
acquisition and maintenance. RCC resources include: (1) personnel with expertise across the spectrum of
translational research methods and statistics, development, and computation/data analysis services for
multidisciplinary health research projects and programs; (2) access and enhancement of computing and
laboratory facilities that focus on multidisciplinary research programs to address health disparities; (3) a rapidly
developing health informatics infrastructure; and (4) a set of strong community partnerships that support the
overall mission of SHERC.